Design and directed evolution of an 'Edmanase' enzyme for high-throughput peptide sequencing.

ABSTRACT More accessible and cost-effective technologies for analysis of the proteome would accelerate biological and medical research. The goal of this proposal is to develop enzymatic reagents to enable creation of a highly-scalable digital protein analysis technology. The approach is broadly applicable and greatly improves upon cost, sensitivity, usability, and throughput of current approaches.

Public health relevance
NARRATIVE This proposal is to develop reagents/technology to enable user-friendly, high-throughput analysis of proteins. By making information about proteins more easily accessible, this technology has the potential to advance basic research in almost every area in molecular life sciences, as well as applied and clinical research, including drug target discovery and drug development.